Division of Chemical Toxicology Symposia at the 270th National ACS meeting

ABSTRACT
The goal of this application is to obtain support for the American Chemical Society Division of Chemical
Toxicology (TOXI) at the 270th National Meeting, scheduled for August 17-21, 2025, in Washington, DC. The
Division's mission is to enhance human health and public welfare by advancing the understanding of chemical
mechanisms involved in disease processes, as well as the toxicity of drugs, environmental agents, and
endogenous chemicals. Our objectives include fostering a diverse forum for sharing research in chemical
toxicology, encouraging studies on chemical mechanisms of toxicity, and promoting collaborations among
academia, industry, and policy makers in areas of shared scientific interest. We are also dedicated to supporting
the leadership and professional development of scientists at all stages of their careers. Therefore, the requested
funds will be allocated to support travel awards and expenses for graduate students, postdoctoral scholars, and
junior faculty. The TOXI program will focus on the theme of "Toxicological Predictions, Markers, and Outcomes
Affecting Human Health," complementing the National Meeting's overarching goals. The program includes three
thematic symposia with invited oral presentations from both established and emerging researchers, offering a
wide range of perspectives on each topic. These symposia are: (1) "Endogenous DNA Damage and Single Base
Repair: Implications for Human Health and Disease," co-sponsored by the Division of Biological Chemistry, which
will explore how environmental toxicants exacerbate endogenous DNA damage and repair; (2) "The Role of
Investigative Toxicology in Drug-Induced Liver Toxicity," co-sponsored by the Division of Medicinal Chemistry,
focusing on novel techniques like machine learning and AI to understand the mechanisms behind drug-induced
liver injury; and (3) "Reactive Metabolite Post-translational Modifications and Their Analysis," co-sponsored by
the Division of Analytical Chemistry, which will highlight analytical techniques for uncovering new modifications,
isotope tracing, and systems-level studies of metabolism-driven post-translational modifications. We will also
host three award symposia: a Young Investigator Award, which is chosen by the ACS journal Chemical Research
in Toxicology, a Founders’ Award, which acknowledges the contributions of a founding member of the TOXI
division, and a Keynote Address from a leader in the world of toxicology. We will also host two student and
postdoctoral symposiums, with oral and poster presentations. The majority of presentations will explore the role
of environmental exposures in disease and health, which aligns closely with the mission of the National Institute
of Environmental Health Sciences (NIEHS).

Public health relevance
The ACS Division of Chemical Toxicology (TOXI) is committed to enhancing our understanding of the chemical processes that contribute to disease development and the detrimental effects of environmental agents, pharmaceuticals, and natural compounds with the goal to improve public health and well-being. This proposal specifically supports TOXI’s scientific programming at the ACS National Meeting, with a focus on sessions that explore the mechanisms and predictions of how environmental agents and their byproducts cause toxicity. The conference serves as a platform for sharing recent discoveries and fostering collaboration among environmental health scientists and chemists across diverse disciplines, aligning with the health-focused missions of the National Institute of Environmental Health Sciences (NIEHS) and the National Institutes of Health (NIH).